Epigenetic regulation of lineage specification in colon epithelial cells

PROJECT SUMMARY
The colon is a responsive tissue, and the epithelium replaces itself every 3-4 days. The colon has dedicated
stem cells that divide for self-renewal and differentiation into specialized cell types. Differentiated colon cells
perform distinct functions including water absorption and mucus secretion. In many tissues, differentiation is
driven by epigenetic mechanisms including histone modifications. Methylation of histone H3 at lysine 36 (H3K36)
is associated with gene bodies at sites of transcriptional activity. H3K36 methylation contributes to differentiation
and stem cell maintenance in rapidly renewing tissues including blood and testes. Based on preliminary data, I
hypothesize that H3K36 methylation governs cell fate decisions and reinforces cell identity in colon epithelial
cells, specifically colonocyte and goblet cell lineages. To address this hypothesis, I will pursue two specific aims.
First, I plan to characterize the H3K36 methylation signature in colon epithelial cells. Second, I will determine the
functional role of H3K36 methylation in colon cell identity. Although, establishing a direct connection between
specific histone modifications and cellular processes is challenging due to redundancies in the system, I can
overcome this obstacle by taking advantage of a lysine (K)-to-methionine (M) mutation first discovered in cancer
patients to precisely suppress H3K36 methylation. I will combine multiple cutting-edge tools to specifically trace
and manipulate H3K36 methylation in mice and organoid model systems to advance the understanding of
chromatin and lineage specification in the colon. I will also utilize novel sorting protocols to purify distinct colon
cell populations for comparative epigenetic and transcriptional analysis. Collectively, this work is significant
because it will establish the role of H3K36 methylation in controlling cell-type specific gene expression and
lineage decisions in the colon. Revealing the role histone modifications play in colon homeostasis is the first step
to understanding how these regulatory mechanisms break down in diseases such as colitis/cancer and could
impact human health.

Public health relevance
PROJECT NARRATIVE Histone modifications serve as key epigenetic marks with dynamic functions in many cellular processes. This proposal aims to characterize the role of histone H3 lysine 36 methylation, a mark of active transcription, in the specification and maintenance of colon cell lineages. Defining the regulatory networks that govern cell fate decisions and reinforce cell identity in the colon is necessary to understand tissue health and disorder.